Regulation of kainate receptor expression in cone bipolar cells

The long term objective of this work is to understand the molecular genetic basis for how the retina
transmits and processes the signals produced when lights are turned off. Cone photoreceptors
mediate vision during daylight and use glutamate as their transmitter. The cone signals are carried
across the retina by two functional classes of bipolar cells, On and Off, which have different
glutamate receptors that cause them to depolarize (ie, signal) either at light-on or -off, respectively.
Each functional class of bipolar cell can be subdivided into 5-6 anatomical types. This study
focuses on the Off bipolar cells that chiefly express sign-preserving kainate-type glutamate
receptors (subunits GluK1-5). Surprisingly, while AMPA receptors predominate at most CNS
synapses, kainate receptors predominate at the cone synapses of most of the Off bipolar cell
types. They are important to study for at least four reasons. First, the temporal signaling properties
of kainate receptors differ from those of AMPA receptors, and these differences are likely to
change the size and timing of the Off signals traversing the retina in as yet poorly understood
ways. Second, the kainate receptors at most well-studied synapses almost always contain the
GluK2 subunit, whereas the Off bipolar cells choose the less well-studied GluK1 subunit as their
main subunit instead. Third, Off bipolar cells express Neto1, an auxiliary receptor subunit that
profoundly alters the in vivo responses of GluK2-containing receptors. The effect of Neto1 on
endogenous GluK1-containing receptors has not yet been studied. And fourth, while the functional
properties of different kainate receptors on the Off bipolar cell have been described, the molecular
basis for their diverse responses has not been established. To determine the subunit basis for
signaling at the Off bipolar cell synapse, we propose to study synaptic responses in mice in which
receptor subunits (GluK1-GluK5) are individually knocked out either permanently or acutely.
Similar studies will be performed to define the role of the auxiliary subunit Neto1 in communication.
Three specific aims will 1) determine the subunits that mediate synaptic responses in Off bipolar
cell types 1a, 2, and 3a; 2) determine the function of Neto proteins in signaling at the Off bipolar
cell synapse; and, 3) determine the physiological function of the GluK1-1d subunit, which is unique
to the retina, the molecular factors that localize the GluK1-1d subunit to the synapse.

Public health relevance
Receptors for glutamate, the main excitatory transmitter in the brain, come in three types of which kainate receptors, functionally, are the least well understood. Kainate receptors have been implicated in the signaling of pain, epilepsy, and mood disorders, and thus understanding more about this class of receptor is relevant to human health. Kainate receptors play a surprisingly large role in retinal signaling where both their function and interactions with drugs can be studied.